Androgen Excess Polycystic Ovary Syndrome Society Meeting

Project Summary/Abstract
The meetings of the Androgen Excess-Polycystic Ovary Syndrome (AE-PCOS) Society are the only ones that
convene the world's largest group of researchers and clinicians specifically focused on androgen-excess
related disorders. Both the Annual and Update meetings bring together diverse participants to discuss their
latest research findings, to encourage future research collaborations and to disseminate relevant and accurate
health information to the clinical community and general public. The attendees represent several regions of the
world and a variety of disciplines including medical, pediatric and reproductive endocrinology, gynecology,
internal medicine, psychologists, epidemiologists, clinical nutritionists and physiologists. The two-day Annual
Meeting has a well-established format consisting of multiple sessions that include invited scientific lectures,
oral and poster presentations, meet-the-professor sessions, all with interactive and/or question and answer
opportunities. We provide travel awards for junior investigators and child care awards to encourage the
participation of the next generation of researchers and clinicians. The one-day Update Meetings, also held
annually, are focused on basic science research and have a specific theme. We have demonstrated
participation by females and underrepresented minorities in our meetings, membership and Board of Directors.
One of the new highlights is increased collaboration with patient support groups and actively engaging patients
and consumers in our meetings. The Society is composed of basic and clinical scientists and clinicians whose
major interest is the etiology, diagnosis, and treatment of androgen excess disorders. The AE-PCOS Society
has successfully organized 17 Annual Meetings, 4 Update Meetings which are organized as satellite meetings
along with the ASRM and Endocrine Society meetings in the USA or stand alone in other international
locations. The Society through its meetings and resultant publications (14 guidelines and position statements)
has had significant impact on dvelopment of criteria for diagnosis, management and treatment strategies for
PCOS.

Public health relevance
Project Narrative This meeting grant proposes support for the Annual and Update meetings of the Androgen Excess-PCOS Society. The goals are to promote knowledge and original clinical and basic research, in every aspect of androgen excess, improving the understanding, diagnosis, treatment, and prevention of these disorders.